A Wireless Multi-function Microscope for Lifetime Imaging of the Brain Tumor Vasculome

ABSTRACTPreclinical and clinical evidence has shown that brain tumors can alter the structure and function of the
central nervous system microvasculature (i.e. CNS vasculome) during progression, therapy and the emergence of
therapeutic resistance. Brain tumor progression related vasculome remodeling occurs via angiogenesis (i.e. new blood
vessel formation). In contrast, non-angiogenic pathways such as ‘co-option’ (i.e. tumor cells hijacking extant blood
vessels) and ‘immunomodulation’ (i.e. vascular changes induced by the infiltration of immune cells) are involved in
antiangiogenic resistance and immunotherapy evasion, respectively. To elucidate the role of these angiogenic and non-
angiogenic pathways on brain tumor progression and therapeutic response necessitates the development of imaging
tools that can characterize early to advanced in vivo changes in the CNS vasculome (i.e. over the lifetime of the disease).
Therefore, our goal is to build a wireless ‘plug-n-play’ multichannel microscope capable of imaging structural/functional
microvascular (~7-10 µm) changes in vivo, over the entire lifetime of a brain tumor. We propose to exploit advances in
miniaturized optics, image sensor design and wireless technology to fabricate a miniature, wireless microscope with
three channels: fluorescence (FL) to image fluorescent brain tumor cells or dyes; intrinsic optical signals (IOS) to image
cerebral blood volume (CBV) and intravascular oxygenation (HbSat); and laser speckle contrast (LSC) to image cerebral
blood flow (CBF). Guided by compelling preliminary data, we will pursue the following Specific Aims: (1) Develop a
tether-free multichannel microscope with on-chip compressed sensing and wireless transmission; (2) Characterize the in
vivo vasculome in angiogenic and co-optive patient-derived (PDX) brain tumor models over their lifetime; and
(3) Characterize in vivo changes in the vasculome induced by the immune microenvironment of brain tumors. Under
Aim1 we will fabricate a specialized image sensor with compressed sensing for ultra-low power wireless operation. After
validation against an equivalent benchtop imaging system, we will image the CNS vasculome in healthy mice without the
confounding effects of anesthetics. This will include identifying microvessel type (i.e. artery vs. vein) with FL, quantifying
vascular morphology and HbSat with IOS, perfusion with LSC, and mapping ‘microvascular connectivity’ by correlating
CBV (or CBF) fluctuations in microvessels. Under Aim2 we will characterize differences in the CNS vasculomes of clinically
relevant angiogenic and co-optive patient-derived xenografts, and assess if the former exhibits larger disruptions in
microvascular connectivity due to vascular remodeling. Under Aim3, we will characterize in vivo differences in the CNS
vasculomes of wild-type and non-immunosuppressed xenografts, to determine if alleviating immunosuppression
increases CBV/CBF/HbSat and promotes recruitment of tumor associated macrophages (TAM). We will create a versatile
3D printed plug-n-play wireless microscope that permits neuroimaging in freely behaving animals at any time, for any
duration, during any task or physiological recording (e.g. EEG). As this microscope can be customized to any fluorophore,
modified for optogenetics or drug delivery, and used for behavioral studies, we believe it will usher in a new era of brain
cancer research, with utility in diseases involving the CNS vasculome (e.g. stroke, Alzheimer’s disease).

Public health relevance
The proposed research is relevant to public health because the development of imaging tools capable of assessing structural and functional changes in the brain’s microvessels (i.e. vasculome) over the life cycle of a brain tumor model will yield invaluable insight into their role in brain cancer progression, tumor spread, and treatment efficacy. The proposed research is relevant to the NIH’s mission because the assessment of changes in the vasculome of patient-derived brain tumor models over their entire lifetime would help elucidate the role of non-angiogenic brain tumor growth in resistance to antiangiogenic therapies, vascular modulation associated with immunosuppression of the brain tumor microenvironment, and help identify new biomarkers and treatment strategies for patients with brain cancer.